The Induction of Reactivity in Optic Nerve Astrocytes

DESCRIPTION (provided by applicant): In both humans and mice, astrocytes form the immediate cellular environment of the ganglion cell axons in the optic nerve head. They occupy up to 50% of the total tissue volume at that location. When the axons of retinal ganglion cells are damaged, they become reactive. In the proposed research we investigate the signaling between optic axons and the astrocyte that triggers this response. The first question is the nature and timing of the changes in gene expression that follow damage to the optic axons. Our preliminary results indicate that very different sets of glial genes are up or down regulated at different times following axonal injury. The experiments of Specific Aim 1 seek to confirm this finding, using an improved model of axonal damage. Specific Aim 2 uses the results of our existing and future expression profiling to identify candidates for the signaling systems that communicate from axons to astrocytes. The candidate signals will be overexpressed, using viral vectors, in retinal ganglion cells. The prediction is that overexpression of an actual signal will lead to the changes in astrocyte gene expression and morphology characteristic of astrocyte reactivity. Specific Aim 3 investigates the hypothesis that the initial response of the astrocytes to axonal damage is a protective one, i.e. that retinal ganglion cells threatened with injury send a distress signal to the ensheathing astrocytes, which then initiate a neuroprotective response. We will test this hypothesis by stressing the optic nerve in transgenic mice carrying mutations that compromise astrocyte communication and motility. The prediction is that the compromise of astrocyte function will worsen the damage to the axons resulting from this stress.

Public health relevance
PUBLIC HEALTH RELEVANCE: In basic biological experiments, we ask what signals pass between retinal ganglion cells and the astrocytes that ensheath their axons in the optic nerve head. We also test the hypothesis that astrocyte activation can be beneficial, serving to protect the ganglion cell axons from pressure-induced damage. All of these studies (whether this hypothesis is correct or not) provide the basic cell biology needed for targeting astrocyte function for therapeutic purposes in glaucoma. __SpecificAimsTextDelimiter__ Specific Aims Signaling between optic nerve axons and astrocytes The broad question - important for the brain and spinal cord as well as the optic nerve - is to understand what induces astrocyte reactivity around damaged axons. In the eye, what signal triggers astrocyte reactivity in the glial lamina when the optic axons are stressed? Such a signal must inevitably exist at the late stages of axonal degeneration, when axons are frankly degenerating and astrocytes always become reactive as part of the mechanism that removes the axonal debris. What is the communication in the earlier phases, before there is overt destruction of the axons? This is particularly important in light of the commonly held belief that a primary function of fibrous astrocytes is to nurture and protect axons. If that is the case, it is likely from first principles that the earliest phase of the astrocyte response to axonal damage is protective. We have clear evidence for differential gene expression in the early phase of the response to nerve crush, as compared to the response at late times, when axonal debris is being cleared. Here we investigate the early phase of the glial response, and we propose a test of this idea. Aim 1. Learn the time course of changes in gene expression by optic nerve astrocytes following damage to ganglion cell axons. In preliminary experiments, we find that optic nerve head genes are up or down regulated following nerve crush in distinct waves, with different functional groups activated at different times. However, the damage in this case was to axons relatively close to the nerve head. A purer case is provided by damage to the nerve intracerebrally, where there is no chance of direct damage to the astrocytes and where there should be better temporal separation of the waves. The hypothesis is that damage to axons far behind the globe will lead to temporally separate up or down regulation of distinct sets of genes. Aim 2. Evaluate candidate pathways of signaling between axons and astrocytes in the glial lamina. In preliminary studies, we have used gene profiling to identify three candidate receptor-ligand pairs. Further early-responding genes will be revealed by the profiling of aim 1. We propose to overexpress components of these signaling systems in retinal ganglion cells, using virally mediated gene transfer. The hypothesis is that overexpression of damage-signaling genes in the ganglion cell axons will lead directly to upregulation of reactivity genes in the astrocytes. Aim 3. Interfere with the astrocytes' structural remodeling following a mild insult to the optic axons. We have observed (Preliminary Results) that a moderate increase of intraocular pressure - 30 mmHg for one hour - leads to obvious morphological changes in the astrocytes of the glial lamina. These occur without any visible signs of damage to the axons, and are reversible. One possibility is that this early astrocyte reactivity is a protective response, which successfully defends the axons from impending damage. We will apply this mild stress in transgenic mice that have disruption of glial intermediate filaments, gap junctional coupling, or cell motility. The hypothesis is that glial reactivity at this early stage is neuroprotective, so that interfering with astrocyte reactivity will increase the axonal damage resulting from mild IOP stress.